Endothelial-Pericyte Crosstalk in Diabetic Stroke

Project Summary
Tissue plasminogen activator (tPA) remains the only FDA-approved therapy for acute ischemic stroke.
Unfortunately, one-third to half of patients with successful recanalization of large cerebral vessels do not have
good clinical outcome. This is in part due to incomplete microvascular reperfusion termed focal “no-reflow”, which
is particularly prevalent in diabetic stroke. The current proposal will determine the role of endothelial-pericyte
crosstalk, mediated by the action of the endothelial eicosanoids epoxyeicosatrienoates (EETs) on pericytes, in
microvascular no-reflow after diabetic stroke in mice. We will test the hypothesis that endothelial-derived EETs
preserve capillary perfusion in brain after ischemia, in part by protecting pericytes from ischemic injury, and that
diabetes reduces microvascular endothelial EETs; thus, leading to greater pericyte injury and capillary damage
after diabetic stroke. We will also determine if EETs protect pericytes by inhibiting G-protein coupled receptor 39
(GPR39). Stroke is induced in mice with and without type 2 diabetic (T2D), and with higher or lower endothelial
EETs (due to transgenic overexpression or deletion of EETs-degrading enzyme soluble epoxide hydrolase, sEH,
in endothelium) using an intraluminal occlusive filament or in-situ thrombin injection to occlude the middle
cerebral artery (MCA). Intra-vital imaging using optical microangiography (OMAG) and two-photon microscopy
(2PM) will be used to assess pericyte morphology, BBB integrity, capillary blood flow, and platelet and leukocyte
morphology and dynamics within the peri-infarct region in-vivo, in real-time after MCA occlusion. Mice will be
survived for 4 days after stroke to assess cellular and tissue damage (H&E, EM, IHC), and for 28 days to assess
long-term functional deficit (neurocognitive and somatosensory). We propose that preserving endothelial-
pericyte EETs/GPR39 signaling protects pericytes, prevents no-reflow and reduces brain tissue damage and
neurobehavioral functional deficit. Enhancing endothelial EETs, either pharmacologically or in transgenic mice
with higher endothelial EETs, will also enhance tPA efficacy and reduce tPA-associated hemorrhage after stroke
in diabetic mice.

Public health relevance
Project Narrative Despite recent progress in stroke therapy, many patients do not improve from current therapies. Current therapies open large brain vessels, which are closed off by a clot in stroke. However, in some patients, especially those with diabetes, small vessels are also closed off; therefore, opening the larger vessels does not benefit these patients. The current project will investigate the role of a cell type called pericytes that is found on the smallest of blood vessels. We will determine if a receptor found on these cells is activated after stroke, leading to their contraction and closure of small vessels, and if drugs that inhibit this receptor can be combined with current stroke therapies to allow the opening of both large and small vessels.